Leveraging Big Data and Deep Learning to Develop Next Generation Decision Support Tools to Improve Glycemic Outcomes in Type 1 Diabetes

Project Summary
The hallmark of type 1 diabetes (T1D) is insufficient insulin production caused by pancreatic beta cell
dysfunction. Most people treat their T1D through multiple daily injections (MDI) of insulin or use of a
transcutaneous insulin pump. Several decision support smartphone apps exist to help people estimate insulin
doses based on continuous glucose monitor (CGM) data and food intake. More sophisticated decision support
tools employ mathematical models of human physiology to predict future glucose levels and provide
generalized insulin therapy recommendations. Exercise is a crucial component of the long-term management
of T1D, however many people avoid physical activity for fear of hypoglycemia (< 70 mg/dL). While consensus
guidelines exist to help people manage glucose during physical activity, people still experience acute
complications. Mathematical models of aerobic exercise yield promise in predicting hypoglycemia during
controlled in- clinic experiments but do not perform well in the real-world or during other types of exercise.
There is a critical need for a decision support system that helps people with T1D maintain safe glucose levels
around exercise of varying types. The goal of this proposal is to develop a decision support tool to help people
with T1D who utilize CGM better manage their glucose surrounding exercise. This tool will be called AIDES,
the Artificially Intelligent Diabetic Exercise Support system. We hypothesize that use of a novel exercise-
specific decision support tool, powered by predictive physiological modelling, artificial intelligence (AI), and
deep learning, can provide treatment recommendations to reduce the number of hypoglycemic events
experienced by people with T1D around regular physical exercise. In our first aim, we will develop a new
model of resistance exercise that describes both insulin- and non-insulin mediated effects on glucose
dynamics. We will then create a novel hybrid computational framework that harnesses AI to augment
physiology models of aerobic and resistance exercise. This hybrid framework, called physAI, will harness real-
world, free-living exercise data from the T1Dexi project (Big Data). In our second aim, we will leverage
decades of research into deep learning with the Big Data provided by the T1Dexi project to train an AI-based
decision support system that gives treatment recommendations to help users maintain target glucose during
exercise. In our third aim, we will assess the safety and usability of our decision support engine in a small
proof-of-concept study with human participants, supported by the Sponsor. This will be the first decision
support system specifically designed to provide treatment recommendations that help users maintain safe
glucose levels while performing aerobic and resistance exercise.

Public health relevance
Project Narrative Type 1 diabetes is difficult to manage during exercise, and few validated tools exist to recommend treatment options to avoid dangerous complications resulting from low blood glucose. This proposal combines physiological modelling and deep learning to develop a novel artificial intelligence decision support system to help multiple daily injection users maintain safe blood glucose levels during and after exercise. We will build and validate this system in three parts: 1) we will tune a decision support system to correctly identify issues in patient glycemic control and recommend appropriate treatment modifications; 2) we will develop a new hypoglycemia prediction tool that reflects the longitudinal dynamics of glucose uptake during and after exercise; and 3) we will explore the performance of this decision support system and hypoglycemia prediction tool in a clinical trial.